Epigenetic drivers of quiescence in artemisinin-resistant Plasmodium falciparum malaria

PROJECT SUMMARY / ABSTRACT:
Malaria, a mosquito-borne parasitic disease caused by Plasmodium falciparum (Pf), remains a significant global
health threat, with ~200 million cases and ~600,000 deaths annually, mainly in children under 5 years of age.
Resistance to the first line antimalarial, artemisinin (ART), has spread across Asia and has now arisen in Africa,
imperiling malaria treatment and control. Despite the pressing need for novel therapeutic targets, discovery of
new fundamental parasite biology lags behind most other pathogens and higher eukaryotes. ART resistance is
primarily mediated by mutations in the K13 protein. While reduced hemoglobin endocytosis plays a central role
in this resistance response, cellular quiescence is also a key component of survival. The drivers of entry into and
exit from drug-induced quiescence remain undiscovered. Quiescence is critical to multiple aspects of parasite
biology, including to the starvation response and in the liver and mosquito stages. In ART-induced quiescence
only a small yet reproducible parasite population survives drug pulse and reinitiates growth, suggesting a role
for epigenetic and epitranscriptomic regulatory mechanisms. We recently uncovered one such mechanism, via
tRNA modification reprogramming, that drug-resistant parasites use to rapidly alter their proteome in a codon-
bias manner as a ‘just-in-time’ translational stress response. We hypothesize that, similar to quiescent tumor
cells and bacterial persister cells, Pf can also use noncoding RNAs (ncRNAs) to alter its transcription and
translation in response to stress. Uncovering these yet unidentified mechanisms will fundamentally alter how we
understand transcriptional and translational control in malaria parasites. By harnessing techniques from tumor
biology and bacterial persister systems, we propose to identify and functionally characterize the roles of ncRNAs
in parasite quiescence. We will use transcriptomics to identify differentially changing long ncRNAs and tRNA-
derived fragments in ART-resistant and ART-sensitive parasites after exposure to ART or to isoleucine
starvation. Candidate ncRNAs will be validated using complementary approaches, including CRISPR/Cas9
conditional knockdowns and in vitro parasite drug susceptibility assays. Molecular mechanisms will be elucidated
using biotinylated candidate ncRNAs as bait to identify interacting RNA binding proteins by mass spectrometry
(MS). We will also test the hypothesis that modifications on the amino-acyl tRNA can regulate ART-mediated
quiescence at the translational level by using a combination of specialized MS and genetic knockdown
approaches. Finally, we will create a novel quiescent reporter parasite line, allowing for live cell sorting of
quiescent parasites. This will provide the first opportunity to examine transcriptomic changes at the single cell
level as parasites enter and exit quiescence. We anticipate that our findings will shift the paradigm of how we
understand gene regulation in drug-resistant, blood stage Pf and that the framework and tools generated herein
can be expanded to other quiescent stages of the parasite lifecycle. Our results will also identify parasite
vulnerabilities that can be leveraged into new strategies to treat ART-resistant malaria.

Public health relevance
PROJECT NARRATIVE The emergence of artemisinin-resistant Plasmodium falciparum (Pf) parasites imperils global malaria treatment and control. Quiescence plays a central role in artemisinin-resistant parasite survival, as well as in the parasite starvation response, but drivers of entry into and exit from this cellular state remain unknown. The proposed research will employ transcriptomics, mass spectrometry and genetic knockdowns to identify and characterize novel epigenetic mechanisms that regulate drug-resistant parasite entry into and exit from quiescence, thereby fundamentally altering how we understand parasite gene regulation and allowing for the development of novel antimalarials to combat one of the deadliest global diseases.